Personal Values in Dementia Experience, Caregiving, and Research

PROJECT SUMMARY/ABSTRACT
Dementia caregivers, clinicians, and researchers can experience deep ethical conflicts when people
with dementia express strong preferences about personal care, finances, clinical management or
research participation that depart from values that they had previously espoused. As values are central
to relationships, such changes can also be destabilizing to caregivers’ own senses of self and
relationships with care recipients. The overall aim of this application is to leverage rich existing
interdisciplinary collaborations including expertise in clinical neurology, philosophy, social science and
psychology to address the unique problems posed by dementia’s progressive effects on fundamental
aspects of personality and judgment. Utilizing key conceptual links between valuing and self-reflection,
the proposed work is organized around three specific aims: 1) Examine self-narratives about values and
change among people with different dementia syndromes; 2) Assess how care recipients’ changing
values and self-narratives impact caregivers and caregiving relationships; and 3) Study longitudinal
change in values of people with dementia and in caregiver responses. Under the first aim, in-depth
qualitative interviews will be conducted with people who have early Alzheimer’s disease and
frontotemporal dementia, inviting them to reflect on their core values and whether they have been
changed in illness; responses will be analyzed alongside neuropsychological data from these
participants to aid in interpretation. For the second aim, caregivers will be interviewed about
experiences in caregiving in the context of changed values or changed expressions of values in people
with dementia; responses will be linked to an established measure of caregiver burden. In the third aim,
dynamic changes in values will be elicited in longitudinal interviews at 1.5- and 3-years’ follow-up, as
the passage of time may allow for healthy adaptation but also dementia progression necessitating
further changes in perceptions of values and relationships. Alongside these investigations, the proposal
includes plans for broad engagement with scholarly communities in multiple disciplines to advance
inquiry into valuing in dementia. The approach is innovative, advancing theoretical concepts in dementia
care and caregiving, and utilizing philosophical theory to inform new approaches to data collection,
analysis, and the linkage of social and neurobiological phenomena. The proposed research is significant
as it will advance both theory and evidence regarding common challenges in decision-making that are
uniquely problematic in dementia, which are implicated in recently-proposed legal and ethical reforms
to bioethical/legal constructs such as supported decision-making; and it will extend research on
caregiving challenges to more deeply personal aspects of caregivers’ relationships and identities.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH SIGNIFICANCE The proposed research is relevant to public health because it proposes new approaches to characterize and address some of the most challenging problems in dementia caregiving, clinical management, and research; building on philosophical frameworks, social sciences methods, and up-to- date neurocognitive findings. Patient values are central to several key bioethical constructs in dementia such as advance care planning, while the centrality of values to relationships means that alterations in the values of people with dementia or how they express their values can contribute to caregiver distress. A fuller understanding of these changes from the perspective of people with dementia and their caregivers will inform approaches to support autonomy and to counsel caregivers in their efforts to adapt to these changes.